Isoquercetin as a PDI inhibitor: dose-optimization and patient phenotyping

PROJECT SUMMARY/ABSTRACT
Dietary flavonoid ingestion has been linked with a reduction in cardiovascular events. We previously made the
serendipitous finding that a specific class of flavonoid quercetins inhibits protein disulfide isomerase (PDI). PDI
is an oxidoreductase that is important for protein folding in the endoplasmic reticulum. However, when released
into the extracellular environment, PDI promotes thrombus formation. Over the past decade, we studied the use
of flavonoid quercetins to target PDI in the context of thrombosis. Our experiments have spanned atomic
resolution studies evaluating structural elements of the flavonoid-PDI interactions to cell-based assays to
preclinical models to human studies. Recognizing the unmet need to develop an antithrombotic agent that is well
tolerated and does not increase the risk of hemorrhage, we focused the clinical development of isoquercetin in
patients with cancer at high risk for developing venous thromboembolism. We previously conducted a phase 2
trial in patients with advanced cancer and observed a significant reduction in circulating plasma D-dimer
consistent with antithrombotic activity. However, before proceeding with a definitive phase 3 trial, we
acknowledge critical gaps in the data package. Importantly, based on recent pharmacodynamic modeling, we
remain uncertain of the optimal dosing schedule, as we currently believe that isoquercetin 1000 mg twice daily
is preferred rather than the previous phase 2 dosing schedule of 1000 mg once daily. We also identified different
prothrombotic mechanisms specifically in cancer, which we believe can identify patients with cancer who are
likely to benefit most from primary thromboprophylaxis with isoquercetin. Our aims in this study are 1) to
determine the optimal isoquercetin dosing based on target PDI inhibition utilizing a PDI-sensitive thrombin
generation assay in patients with ovarian cancer, a group particularly at risk for thrombosis; and 2) to identify
which hypercoagulable phenotypes of cancer are most amenable to PDI inhibition, and thus aiming to tailor
treatment more effectively and advance a personalized approach to thromboprophylaxis in cancer care. In
summary, this study seeks not only to refine isoquercetin therapeutic dosing schedule but also explore function-
activity relationships of isoquercetin in specific hypercoagulable contexts, thereby enabling a phase 3 trial to
develop a more targeted, safe, and effective approach toward prevention of cancer-associated thrombosis.

Public health relevance
PROJECT NARRATIVE Extracellular protein disulfide isomerase (PDI) regulates blood clot formation. We previously demonstrated that quercetin flavonoids inhibit PDI activity and prevent blood clot formation in both preclinical and human studies. This study aims to optimize isoquercetin dosing schedule and refine patient selection characteristics in order to facilitate the conduct of a phase 3 clinical trial.